Role of estrogen receptor beta in polychlorinated biphenyls impacts on bladder function

PROJECT SUMMARY
Lower urinary tract symptoms (LUTS) pose a significant healthcare and quality of life burden. Therapeutic
strategies mainly target symptom improvement, primarily because underlying cause(s) are not well understood.
The complex etiology of LUTS may include exposure to environmental chemicals such as polychlorinated
biphenyls (PCBs), persistent organic pollutants that are ubiquitous in the environment and still unintentionally
produced despite worldwide bans. Since PCBs consist of different structural variants in varying proportions in
the environment and in people, we use a human-relevant PCB mixture known as MARBLES PCBs which mirrors
the most abundant PCB congeners and their relative concentrations as measured from the blood serum of
pregnant women in the Markers of Autism Risk in Babies-Learning Early Signs (MARBLES) cohort. PCBs can
be endocrine disruptors, including directly binding to estrogen receptors and inducing estrogen receptor
mediated gene transcription, but if and how PCBs influence bladder function is understudied. We previously
demonstrated that MARBLES PCBs exposure in mice causes augmented urinary voiding physiology and bladder
contractility. Study of PCBs’ mechanism(s) of action to perturb urinary voiding function is still ongoing, but
preliminary data suggests that increased big potassium (BK) channel expression in the detrusor smooth muscle
cells contributes to the observed voiding changes. Therefore, since literature supports the individual actions that
PCBs can bind to and activate ERβ, ERβ agonism can increase BK channel expression, and increased BK
channel expression in urinary bladder smooth muscle can impact urinary voiding physiology, I hypothesize that
in utero and lactational exposure to human-relevant PCBs directly act upon ERβ which alters urinary
voiding function via increased big potassium (BK) channel expression in mice at 6 weeks of age. We will
address the hypothesis by characterizing MARBLES PCB’s ability to induced gene transcription of estrogen
receptor beta in vitro. Then, in vivo utilizing control genotype and ERβ knockout mice, we will developmentally
expose mice to vehicle control or the MARBLES PCB mixture. We will test developmental MARBLES PCB
exposure’s effects on BK channel expression, bladder contractility, and urinary voiding physiology, and also
elucidate ERβ’s role in affecting PCB adverse outcomes. Our studies will have far-reaching effects on elucidating
the molecular mechanism of how human-relevant PCBs impact bladder function and disrupt steroid hormone
action. It is of great importance for human health to understand the etiology of these complex pathologies and
identify targets for pharmacological interventions. And more broadly, this proposal highlights how the intersection
on toxicology, urology, and endocrinology can result in basic research that has wide outcomes for human health
benefits.

Public health relevance
PROJECT NARRATIVE Lower urinary tract symptoms are complex pathologies, to which the environmental chemical polychlorinated biphenyls may contribute by altering urinary bladder contractility through the proposed mechanism of estrogen receptor β (ERβ) binding which increases big potassium (BK) channel expression in the urinary bladder smooth muscle. This study will utilize an in vitro estrogenic cell line and an in vivo mouse line with ERβ globally knocked out, including the bladder smooth muscle, to determine if the proposed mechanism contributes to PCB’s adverse outcome on urinary voiding. Such studies are essential for elucidating the pathogenesis and treatment targets for people suffering from lower urinary tract symptoms.